Synaptic and cellular mechanisms of neuronal synchronization

Project Summary/Abstract
Neuronal activity must be precisely coordinated to provide an accurate representation of our environment, a
feature exemplified by the electrical patterns measured in the brain during spatial navigation and memory
retrieval. While the activity of individual neurons is tuned to specific features such as physical location or speed,
simultaneous observations at the network level reveals electrical oscillations reflecting the coordinated activity
of thousands of neurons. Therefore, a central goal of neuroscience is to understand how network activity
emerges from the interactions between individual neurons. The neuronal architecture is relatively well-conserved
across multiple brain regions: a population of highly heterogenous inhibitory interneurons (INs) with dense
connectivity control a large population of excitatory neurons. Thus, the mechanisms controlling INs themselves
are poised to have a dramatic impact on network activity. Previous studies support the existence of small
populations of INs that selectively synapse onto other INs. These relatively sparse INs operate disinhibitory
networks that could have a profound impact on network activity. Here, I investigate how coordinated activity
emerges from neuronal interactions by investigating how disinhibition controls hippocampal circuits. In Aim 1, I
will dissect a disinhibitory circuits controlling parvalbumin-expressing (PV) INs, a class of neurons controlling the
firing of pyramidal cells. My preliminary results show that an overlooked class of INs known as backprojecting
(BP) INs hierarchically control PV-INs. I devised an intersectional genetic strategy to specifically access BP-INs
and establish their role in the network. Under Aim 2, I will explore how disinhibition maintains temporal neuronal
sequences, a hallmark feature of coordinated neuronal activity during network oscillations. I will focus on when
and how BP-INs are recruited during network oscillations and on the downstream effects of their activity by
working in vitro. Under Aim 3, I will reconstruct the impact of disinhibitory neurons on hippocampal network
dynamics. I will determine the necessity and the sufficiency of BP-INs in controlling hippocampal network
oscillations at different phases. Overall, this research will shed light on the physiological functions of disinhibition,
a well-conserved, but generally understudied circuit feature. During the K99 phase of the award, I will benefit
from the mentorship of Drs. Tsien and Buzsáki at New York University Grossman School of Medicine to obtain
additional training in system neuroscience. The training plan proposed will equip me with the necessary research
and professional skills to start an independent career at the intersection between cellular and system
neuroscience in the R00 phase. This work is further motivated by observations that dysregulation in neuronal
coordination can lead to neurological disorders such as autism spectrum disorders and epilepsies. In the long
term, studying how inhibitory neurons and disinhibition control neuronal network activity will provide a better
understanding of these pathological conditions.

Public health relevance
Project Narrative Neurons in the brain are precisely orchestrated to provide an internal representation of our environment, a vital yet incompletely understood function. Here, we focus our attention on an overlooked population of inhibitory neurons in the brain to investigate how synapses and neurons cooperate to synchronize neuronal activity across a network. The proposed research will expand our knowledge on the fundamental mechanisms underlying neuronal network coordination, with our findings having potentially far-reaching impact for our understanding of neurological disorders such as autism spectrum disorders, schizophrenia, and epilepsies.